Seattle Affiliated Core Site

The Seattle Affiliated (SA)- AMC Core Site will unite 3 Northwest regional institutions, each one bringing unique strengths to the alliance, to create a single core site with robust enrollment that functions efficientiy and makes significant contributions to the consortium both in terms of subject accrual and scientific leadership through participation on AMC working groups and protocol development.